Core 3: Biostatistics Core

CORE 3 - SUMMARY
Core 3 will collaborate and consult with P01 Investigators on study design and data analysis to ensure the
translational and mechanistic research will satisfy high scientific standards for statistical rigor. The requested
funding will provide statistical support to the human studies and cell line experiments proposed in Projects 1-3,
including collaboration with Core 1 on data management and computational components. In particular, the
Biostatistics Core is a dedicated facility to provide ready and specialized access to:
Aim 1: Statistical expertise for the design, planning and conduct of human studies and cell line experiments.
Sample size considerations are critical in comparative studies of radiation modalities with dosimetry, imaging,
circulating and tissue biomarkers.
Aim 2: Statistical expertise for data analysis, interpretation and reporting of human studies and cell line
experiments. Analysis plans include (a) development and validation of risk prediction models (b) assessment of
adding a biomarker based on model performance (c) mediation modeling to decompose causal relationships
into direct and indirect effects of radiation-induced lymphopenia or DNA damage response on patient outcome.
Aim 3: Database consultation with Core 1 on (a) forms design, including coding conventions and variable
formats (b) database specifications, including formatting of output datasets (c) quality control and audit
processes.

Public health relevance
CORE 3 - NARRATIVE The Biostatistics Core is critical to the objectives of the P01 in order to ensure the proposed studies meet rigorous scientific standards. Successful translational of the pre-clinical models and human studies to patient care can be accomplished only if the results were statistically valid in terms of experimental design, data analysis and overall interpretation.